Facilitating Endogenous Bone Repair in Arthritis with Targeted IL-27 Sonodelivery

PROJECT SUMMARY
Improved control over synovial inflammation is anticiapted to slow bone erosion and reduce the risk of
fractures and pain. However, even potent anti-inflammatory strategies such as blockade of TNF or IL6R, only
show limited bone repair, suggesting that suppressing inflammation is insufficient to restore osteo-immune
balance. Some current and emerging therapies succeed in slowing erosion by suppressing osteoclast activity,
but fail to significantly stimulate bone formation. Further, these biologics are not targeted for accumulation at
inflammed joints, thus are administered systemically, enhancing the likelihood of serious infection. For
therapeutics to succeed in promoting bone repair, they likely must balance levels and activity of several
proinflammatory cells to disrupt their interaction with osteoclasts, and promote osteoblast maturation or activity.
Thus a critical unmet need for inflammatory bone loss is an intervention that can restore eroded bone through
rebalancing immune:bone cell homeostasis in order to reduce fracture risk and improve quality of life for
patients. Recent data points to a novel use for cytokine Interleukin-27 (IL-27) as a regulator of immune and
bone cell balance, as it reduces osteoclastogenesis and promotes osteoblast proliferation and maturation.
Also, IL-27 suppresses activities of immune and synovial cells mediating the onset and maintenance of
inflammation and also has anti-angiogenic activity. Current strategies for delivering recombinant (r)IL-27 are
systemic and lack specificity to immune or bone cells, and moreover are unable to sustain therapeutic effects
over time due to rapid clearance. We propose to examine whether a targeted IL-27, delivered using a
sustained expression system, will be effective in promoting bone repair and reducing inflammation in joints
using a collagen-antibody induced arthritis (CAIA) model. Intraarticular sonoporation gene delivery
(sonodelivery) will transfer into the joints a nanoplex of polymer and plasmid DNA encoding targeted IL-27 to
reduce inflammation and promote bone repair. Our hypothesis is that optimizing delivery and targeting of IL-27
to joints will facilitate endogenous bone repair by re-balancing osteo-immune homeostasis.
To test this hypothesis, we propose 1) To achieve therapeutic levels of cytokine in joints, we will optimize
IL-27 intra-articular sonodelivery; 2) To enhance cytokine retention in bone and promote endogenous bone
repair, we will promote ligand-mediated targeting of IL-27 to bone cells or matrix, and 3) To enhance cytokine
retention at the pannus and synovial lining and facilitate bone repair, we will promote ligand-mediated targeting
of IL-27 to inflammatory and immune cells. We anticipate that this simple sonodelivery strategy will provide an
efficient means to restore eroded bone in articulations affected by rheumatoid arthritis (RA). IL-27 is unique in
its ability to simultaneously inhibit inflammation and promote bone repair. This approach is exciting in that we
envision applications across numerous conditions characterized by bone loss.

Public health relevance
PROJECT NARRATIVE A critical unmet need for treating bone erosion associated with inflammatory arthritis is an intervention that provides short-term control of inflammation by rebalancing inflammatory, immune, and bone cell interactions, and stimulates long-term restoration of eroded tissues to relieve pain and reduce the need for surgical intervention. Recent data suggests that the multifunctional cytokine IL-27 is a very promising candidate since it promotes balance between immune and bone cell populations to reduce bone erosion and promote bone repair by osteoblasts. Our approach proposes to utilize the novel method of sonodelivery for localized transfer of bone- or immune cell- targeted IL-27 to faciliate endogenous repair of bone erosions associated with inflammatory arthritis.